How membrane lipids mediate ciliary signaling

Project Summary/Abstract
Mutations of the Polycystin complex, consisting of a 1:3 ratio of membrane-spanning proteins Polycystin (PC) 1
and 2, result in autosomal-dominant polycystic kidney disease (ADPKD) in humans. ADPKD is monogenic and
the most common form of polycystic kidney disease (PKD). The Polycystin complex localizes to the ciliary
membrane, where it performs unique roles in cell signaling and maintenance of kidney function. While the role
of these membrane proteins at the primary cilium has begun to be identified, relatively little is known about the
membrane lipid composition of the primary cilium or its role in ciliary Polycystin signaling. Cellular membranes
are well established as essential signaling components within and between cells, but there is significant
unexplored area to cover in the field of ciliary membrane biology. We aim to discover the relationship between
membrane lipid phosphatidylserine and the Polycystin complex within the primary cilium. I propose to utilize a
tool I developed to deplete ciliary phosphatidylserine in vivo and in vitro to test a novel parameter that may
impact Polycystin channel localization and signaling. This tool, named cilia-PISD, encodes a fusion protein that
includes the ciliary localization sequence of Arl13b, mCherry, and phosphatidylserine decarboxylase, an
enzyme that depletes phosphatidylserine in the cell. In Aim 1, I propose to assess the role of ciliary
phosphatidylserine in Polycystin signaling in vivo. I will achieve this aim by injecting cilia-PISD mRNA into the
yolk of developing zebrafish embryos to observe tissue development consequences during the early stages of
development. I hypothesize that I will observe phenotypes consistent with previously described zebrafish
polycystin mutations, including pronephros cysts and craniofacial defects. In Aim 2, I propose to assess the
role of ciliary phosphatidylserine in Polycystin signaling in vitro. I propose to investigate the role of ciliary
membrane phosphatidylserine in the localization of the Polycystin complex and cilia electrophysiology. I will
stably express cilia-PISD in IMCD3 cells, and I will assess changes in polycystin localization with
immunofluorescent staining for polycystin proteins PC1, visible with a surface HA tag, and PC2. I hypothesize
that ciliary PC1 localization will be destabilized in the absence of phosphatidylserine because of recent work
describing that the PLAT domain of PC1, a single subunit of the Polycystin tetramer, has binding specificity for
negatively charged phospholipids including phosphatidylserine. I will also assess changes in ion channel
function in IMCD3 cells stably expressing cilia-PISD via ciliary patch clamping. I hypothesize that loss of ciliary
PS will increase the open probability of ion channels in the primary cilium. Completion of the proposed
experiments will apply a novel tool for ciliary lipid perturbation and analysis and provide key insight into the role
of membrane lipids in Polycystin localization and signaling. Together, these findings will also be a foundation
for clinical understanding of diseases of ciliary origin that may arise from membrane lipid mis localization.

Public health relevance
Project Narrative The primary cilium is capable of complex and dynamic signal transduction mediated by unique localization and concentration of molecules, peptides, and lipids within the ciliary compartment. We adapt and develop a novel tool to decipher the role of phosphatidylserine, a low abundance negatively charged membrane phospholipid that is enriched at the primary cilium, in ciliary Polycystin signaling. Further clarifying the membrane lipid environment at the primary cilium will strengthen our understanding of the basic biology of ciliary signal transduction and focus therapeutic avenues for treatment of diseases of ciliary origin.